Cell Biology of Reovirus Infection

Most viruses that replicate in the cytoplasm form neoorganelles that serve as sites of viral genome replication
and particle assembly. These highly specialized viral factory (VF) structures concentrate viral replication
proteins and nucleic acids, limit activation of cell-intrinsic defenses, and coordinate release of progeny particles.
Despite the importance of VFs in viral replication, there are key gaps in knowledge about how these organelles
form and function. Reovirus is a genetically tractable double-stranded RNA (dsRNA) virus that has been linked
to celiac disease and shows promise for oncolytic applications. The proposed research will define mechanisms
of reovirus factory formation, genome replication and translation, and progeny particle release. In common with
other dsRNA viruses, including important pathogens of animals (orbiviruses) and humans (rotaviruses), reovirus
factories are nucleated by viral nonstructural proteins that recruit viral structural proteins for genome replication
and capsid assembly. We have discovered that (i) nonstructural protein µNS forms VF-like structures that
resemble biomolecular condensates formed by liquid-liquid phase-separation (LLPS), (ii) nonstructural protein
σNS interacts with RNA polymerase λ3 to promote RNA synthesis, and µNS interacts with host protein ATXN2L
to enhance viral translation, and (iii) progeny particles are transported from factories and released using a
vesicular sorting mechanism dependent on modified lysosomes and actin-like filaments. Three integrated
specific aims are proposed to fill knowledge gaps about reovirus factory biogenesis, replication and translation,
and progeny particle egress. In Specific Aim 1, VF properties of µNS will be elucidated using biochemical and
cell-imaging assays established to define LLPS condensates. The structure of µNS will be determined using X-
ray crystallography and cryo-electron microscopy (cryo-EM). Host proteins that contribute to factory maturation
will be examined using rapid proximity-dependent biotin identification (TurboID) of µNS-interacting partners. In
Specific Aim 2, mechanisms by which reovirus factories facilitate viral replication and translation will be
evaluated. The function of σNS in viral genome replication will be defined by determining the structure of σNS
in complex with λ3 and RNA along with assays of RNA polymerase activity. The function of ATXN2L in
synthesis of viral proteins will be determined using ribosomal sequencing and cellular and in vitro translation
assays. In Specific Aim 3, the process by which mature virions are transported to the cell surface and released
will be visualized using single-particle cryo-EM and cryo-electron tomography. Host proteins required for
nonlytic reovirus egress will be identified using candidate and unbiased screening approaches and validated
using replication and egress assays. These studies will enhance an understanding of mechanisms by which
pathogenic viruses alter cellular architecture to engineer replication organelles, coordinate key replication
functions, and exit infected cells. This information may foster development of antiviral drugs that impede these
essential viral replication steps and improve the use of reovirus as an oncolytic therapeutic.

Public health relevance
The proposed research will contribute new knowledge about how pathogenic viruses establish intracellular replication factories, produce new viral RNA and protein, and exit infected cells to cause disease. This information will identify new targets for antiviral drug development and stimulate progress in the use of viruses for cancer therapy.